Harmonized Diagnostic Assessment of Dementia (DAD) for Longitudinal Aging Study of India (LASI)-Genomic study

Summary
Genetic factors play an important role in Alzheimer’s disease (AD), and there is evidence
that genes may play a bigger role in cognition as we age. Our preliminary analysis of the whole
genome sequences from LASI-DAD shows that our study has the most comprehensive survey of
genetic variation in South Asia. Further, we have uncovered that like most non-Africans, South
Asians have ~1-3% ancestry from archaic hominins––Neanderthals and Denisovans. Surveys of
Eurasians have shown that this history has played a critical role in shaping the genetic and
phenotypic variation in modern humans. For instance, archaic ancestry in Eurasians has impacted
numerous traits ranging from skin pigmentation to high altitude adaptation, and response to
SARS-CoV-2. However, most studies have focused on Europeans and East Asians, with very few
genomes from other parts of the world. Further, no study has investigated the role of archaic
ancestry in impacting the risk of Alzheimer’s disease or cognitive phenotypes.
To fill this gap, we aim to investigate how archaic hominins (Neanderthal and Denisovan)
ancestry impacts the risk of Alzheimer’s disease and cognitive phenotypes in modern humans
using the large dataset of 2,700 samples from our LASI-DAD study. The LASI-DAD dataset
contains 2,700 individuals from diverse ethnolinguistic groups in India, with extensive phenotype
information for Alzheimer’s disease risk and cognitive phenotypes. The detailed genotype and
phenotype information from the LASI-DAD dataset provides a unique opportunity to study the
impact of Neanderthal, Denisovan and introgressed segments from other unknown hominins on
the health of present-day individuals and uncover introgressed genes associated with Alzheimer's
disease risk. Moreover, we are currently collecting more samples from additional regions and the
study is a very timely project as we can collect more samples from specific groups to increase our
power for genotype-phenotype analysis that show promising results.
In this application, we propose the following specific aims: (1) to generate a map of archai
introgression in modern humans; (2) to perform association analysis to study the association of
Alzheimer’s disease risk and archaic ancestry; (3) to recruit samples from additional regions to
maximize its potential for future population genomics study.

Public health relevance
Public Health Relevance Statement While surveys of Eurasians have shown that ancestry from archaic hominins – Neanderthals and Denisovans – has played a critical role in shaping the genetic and phenotypic variation in modern humans, most of these studies have focused on European and East Asians with very few genomes from other parts of the world. We aim to fill this gap by investigating how archaic hominins ancestry impacts the risk of Alzheimer’s disease and cognitive phenotypes in modern humans using the LASI-DAD study in India. Our proposed work will yield new insights to genomic architecture of Alzheimer’s disease and related dementias.